Web-Based Resource for Genomic Enzymology Tools

PROJECT SUMMARY/ABSTRACT
This application requests support for a web-based resource that provides community access to “genomic
enzymology” tools to 1) enable identification of uncharacterized proteins for functional discovery, including those
that are present in human microbiome and other metagenomic communities; 2) facilitate assignment of function
to uncharacterized proteins by providing easy access to genome context/functional linkage; and 3) survey
sequence-function space in protein families for identification of candidates for functional screening and
improvement of desired biochemical/biophysical properties (useful for systems biology as well as the
pharmaceutical and chemical applications). The resource provides three integrated tools: 1) EFI-EST for
visualization/analysis of sequence-function space in proteins families using sequence similarity networks
(SSNs); 2) EFI-GNT for visualization/analysis of genome context for microbial and fungal proteins in SSNs using
genome neighborhood networks and genome neighborhood diagrams to identify functionally linked proteins
(e.g., enzymes, transporters, and transcriptional regulators in novel metabolic pathways); and 3) EFI-CGFP for
chemically guided functional profiling that maps metagenome and/or meta-transcriptome abundance to clusters
in SSNs for identification of important microbiome targets for functional characterization. The resource enables
access to the tools without the need for users to have computer programming expertise and/or local access to
the necessary computational infrastructure. The resource has been available since 2014; its development and
dissemination have been supported by U54GM093342 and P01GM118303. The resource has been accessed
by >5,000 domestic and international users and cited in >300 publications and patents, confirming its ease-of-
use, popularity, and impact.

Public health relevance
PROJECT NARRATIVE Bioinformatics tools that are easily accessible to experimentalists are required to leverage the large (and rapidly increasing) protein, genome, and metagenome databases to facilitate experimental assignment of functions to uncharacterized proteins discovered in genome projects (in vitro activities and in vivo metabolic/physiological functions). This application requests support for continuation of an NIGMS-developed web resource that provides community access to “genomic enzymology” tools to 1) construct sequence similarity networks for protein families so that sequence-function space can be visualized and analyzed (EFI-EST), 2) generate genome neighborhood networks and genome neighborhood diagrams so that genome context can be used to identify functionally linked proteins in bacteria, archaea, and fungi and propose metabolic pathways (EFI-GNT), and 3) map metagenome abundance to proteins in sequence similarity networks using chemically guided functional profiling so that important targets in microbiome communities can be identified for functional assignment (EFI- CGFP). This resource, developed and disseminated with the support of U54GM093342 and P01GM118303, has been cited in >300 publications and patents, confirming its ease-of-use, popularity, and impact.